“Cortical electrophysiology of response inhibition and implications for DBS therapy in patients

Project Summary – Project 4
Parkinson’s disease (PD) is associated with behavioral impulsivity and deficits in motor control which result in
an inability to cancel planned actions or stop ongoing movements. These behaviors are affected by deep brain
stimulation (DBS) and levodopa treatment. The prefrontal cortex and its connections to the subthalamic nucleus
(STN), the main target of DBS therapy for PD, have been implicated in the control of these ‘response inhibition’
functions. It has been proposed that modulation of prefrontal-STN connections by DBS can change response
inhibition behavior, but clinical studies of this interaction have been conflicting, and clinical programming of DBS
devices continues to focus on the optimization of the motoric outcome of DBS, with little attention to the potential
changes in cognition and behavior which may result from DBS. The effects of dopaminergic medications on
motor response inhibition are also not well understood. While large-scale changes such as outright compulsive
disorders are often recognized, more subtle shifts in behavior are not usually acknowledged. The proposed
experiments will study the pathophysiologic underpinning of response inhibition abnormalities in PD, asking
which cortical mechanisms are engaged in different aspects of motor inhibitory control (proactive vs reactive;
discrete vs continuous) in patients off and on levodopa therapy, compared to healthy controls, and examine
whether the effects of STN DBS on response inhibition correlates with the degree of activation of the prefrontal
cortico-STN pathway. We will use invasive and non-invasive electrophysiology methods, as well as computa-
tional modeling. We will study patients longitudinally (before, during and after DBS procedures) and measure
their performance and cortical activity while they perform two response inhibition tasks. We will define the degree
of prefrontal cortico-STN pathway activation by different stimulation settings, using both direct electrophysiologic
recordings (subcortico-cortical evoked potentials) and state-of-the-art computational biophysical models. We will
also study how behavior and the underlying electrophysiologic activity change with levodopa treatment, and how
these alterations relate to the results of standard clinical neuropsychological tests. In addition to the PD patients,
we will study control subjects to understand to what extent changes in PD differ from healthy behavior and
physiology. We hypothesize that the stimulation location and the extent of stimulation field produced by STN-
DBS determine the degree of prefrontal cortex engagement and impact the patient’s ability to inhibit actions. We
postulate that by developing a detailed understanding of how these changes arise, both locally and throughout
the cognitive and motor networks, we can design stimulation strategies that maximize motor benefit and minimize
negative behavioral side effects of DBS. Successful completion of the proposed studies will thus inform DBS
targeting and programming strategies. The proposed Catalyst clinical study will synergize with the other Udall
Center components by focusing on cortical electrophysiology and exploring cortical-subcortical interactions that
lead to motor/cognitive dysfunction in PD, specifically as it relates to STN-DBS.